Preclinical development of VAX024 - a novel targeted combination STING agonist/oncolytic agent

PROJECT SUMMARY
Vaxiion Therapeutics (www.vaxiion.com) is proposing to develop VAX024, a novel, second generation
recombinant bacterial minicell (rBMC)-based targeted oncolytic in situ immunization (ISI) agent purpose-built to
work in STING-positive solid tumors. ISI agents are an emerging class of immunotherapies that use the patient’s
own tumor while still in place to generate first a local innate immune response that is followed by a systemic
antitumor immune response and durable protective immunologic memory. Oncolytic viral therapies (OVs) have
paved the road for ISI agents and have demonstrated clinical activity as evidenced by the market approval of
IMLYGIC™. However, Imlygic and other OVs suffer from two insurmountable limitations: (1) their activity is
severely limited in tumors expressing Stimulator of interferon genes (STING), and (2) they require pharmacies
to have BSL-2 capabilities for clinical preparation, the scarcity of which limits patient access to OVs. In addition,
OVs have a negative impact on quality of life for patients who must continue collecting, storing, and returning
wound dressings, bleaching their toilets after use, and who are not allowed be around immunocompromised or
pregnant family members while on therapy. As described herein, VAX024 circumvents the limitations of OVs in
a single product concept by leveraging our proprietary rBMC delivery technology to generate a sterile, user-
friendly oncolytic agent that is also equipped with a potent clinically validated pan-allelic STING agonist. The
value proposition of VAX024 is a first-in-class oncolytic agent specifically designed to work in STING positive
solid tumors while broadening patient access in comparison to OVs. Our preliminary work demonstrates a high
prevalence of STING expression across solid tumor indications where it is significantly correlated with better
progression free survival. The foundational premise and construction of VAX024 has already been demonstrated
in preliminary in vitro experiments. The overarching purpose of this SBIR Phase 1 proposal is to generate IND-
enabling in vivo proof-of-concept and proof-of-mechanism data, as well as establishing some of the CMC
methodologies that will be needed to support an IND for VAX024. Our team has already brought a first generation
rBMC-based targeted oncolytic agent to the clinic and will leverage our experience and talent to quickly propel
VAX024 through IND submission and into patients.

Public health relevance
PROJECT NARRATIVE Vaxiion Therapeutics has developed an entirely new class of tumor-targeted oncolytic immunotherapy based on recombinant bacterial minicells (rBMCs), the first of which, VAX014, is now being investigated in two Phase 1 clinical trials. The company now proposes to initiate IND-enabling preclinical proof-of-concept studies on a second rBMC-based product, VAX024 that is designed a unique dual mechanism that combines an oncolytic mechanism with a potent pan-allelic STING agonist. This product is designed to cure the deficiencies of oncolytic virus (OV) agents because it is purpose built to work in STING-positive tumors (a major efficacy bar for all OVs) and does not require clinical preparation in BSL-2 facilities nor the cumbersome biohazard mitigation procedures hampering OV use and patient quality of life alike.